Evaluating a remotely delivered, digital health CRC screening intervention among rural patients of a community health center

Colorectal cancer (CRC) screening is one of the most effective tools to reduce cancer morbidity and mortality. Yet, CRC screening rates at federally qualified health centers (FQHCs) in rural areas lag behind more well-resourced healthcare systems and national goals. Improving CRC screening in rural FQHCs requires attention to the needs of their patient populations as well as their limited resources for implementation; yet, little research has tested CRC screening programs with FQHCs that use effective messaging for the patient population and alleviate implementation burden. Our long-term goal is to scale implementation of CRC screening solutions that will reduce burden on FQHCs. Our team has developed a novel digital health platform, mPATH-Cloud, that has the potential to help alleviate implementation burden on clinical teams by automating many key processes, all the while delivering CRC screening communication, education, and services in ways that have proven to be patient-centered and effective. Thus, our study seeks to evaluate mPATH-Cloud with rural FQHCs to demonstrate effectiveness at improving guideline concordant screening and identify critical implementation processes and outcomes that will impact future dissemination and scalability. We will use an embedded experimental mixed methods model, which includes an individual randomized trial of the multi-component intervention, quantitative and qualitative measures to identify ways to improve tailored messaging and adapt strategies to improve effectiveness across patient profiles, and quantitative and qualitative measures of processes and outcomes to improve implementation. Our team is well-situated to lead this research, which if successful, will lead to progress toward improving screening in low-income rural communities served by FQHCs.

Public health relevance
mPATH-Cloud is an innovative digital health platform that delivers evidence-based communication and navigation to help patients receive colorectal cancer screening, a widely recommended test that decreases mortality. However, while this type of technology has proven effective for routine, face-to-face primary care appointments, there is increasing interest and demand for reaching more patients beyond the confines of the traditional clinical visit. This project will determine the effectiveness and optimal way to implement mPATH-Cloud as fully remote strategy for increasing CRC screening among low-income, rural patients.